An Easy-to-use, iNtelligent, Affordable LinEr (ENABLE) System for Socket Fit Assessment

PROJECT SUMMARY
Lower limb amputees rely on prosthetic sockets as the interface with their prosthetic legs. The prosthetic sockets
only work well if they fit residual limbs of amputees perfectly. Unfitted sockets cause various health issues for
lower limb amputees and could significantly limit amputees’ functionality. Currently, prosthetists lack the
capability to diagnose socket fit during the socket fitting procedure, which limits their capability to customize
the sockets for better fit. The proposed Easy-to-use, iNtelligent, Affordable LinEr (ENABLE) System for Socket
Fit Assessment（ENABLE） system will be used as a diagnosis tool for prosthetists. Based on a novel material,
which changes color based on loaded pressure, this Enable system will permit prosthetists to evaluate the socket
fit by observing the pressure distribution on the residual limb directly. During the proposed project, we will
develop the smart liner system and test it through both bench tests and human subject tests. We will also validate
that prosthetists will be able to use the smart liner to make appropriate socket fit diagnosis through simulated
clinical cases.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The proposed research is relevant to public health because the developed ENABLE system will improve the capability of prosthetists to diagnose sockets fit issues. This, in turn, enables prosthetists to have better control of pressure distributions on the residual limb, which leads to more comfortable prosthetic sockets, better user experience for amputee patients, and better quality of life. The project is relevant to the part of the NIH’s mission such that developing the capability to measure pressure distribution on the residual limb will help to improve prosthetic fit, which prevents skin damage on amputees’ residual limb, encourage prosthesis usage, and improve the health of lower limb amputees.